Targeting Acid Ceramidase to Improve the Efficacy of Herpes Oncolytic Virus

PROJECT SUMMARY/ABSTRACT
Dysregulated sphingolipid metabolism is associated with neurodegenerative disorders and cancer, but the
balance between ceramides and sphingosine-1 phosphate that is critical for regulating cell fate, the sphingolipid
rheostat, is less well-studied in neural stem cells or brain tumors. Ceramides can be converted by ceramidases
to sphingosine, which can then be converted by sphingosine kinase 1 to sphingosine-1-phosphate. Shifts toward
sphingosine-1-phosphate production may allow cells to evade apoptosis, while shifts toward ceramides may
favor cell death. In the deadly brain tumor glioblastoma (GBM), a shift in the sphingolipid balance towards
sphingosine-1-phosphate can be mediated by acid ceramidase (ASAH1). ASAH1 is highly expressed in GBM,
including in the radio- and chemoresistant neural stem cell-like brain tumor initiating cells. ASAH1 inhibitors
increased pro-apoptotic ceramides and blocked the progression of some cancer types. Supporting the potential
of targeting ASHA1 for anti-GBM treatments, our novel preliminary data demonstrated that the blood brain barrier
penetrant ASAH1 inhibitor, carmofur, reduced BTIC cell growth as did ASAH1 knockdown. A recent report
using Asah1 knockout mice also demonstrated that acid ceramidase in macrophages inhibited herpes virus
propagation. Immunovirotherapy, specifically oncolytic herpes virus (oHSV), has demonstrated significant
improvement in survival for pediatric high-grade glioma in clinical trials. Unfortunately, the same extent of
response has not been observed in adult GBM. Together, these data suggest that targeting of ASAH1 may
improve oHSV efficacy. We will, therefore, determine if genetic or pharmacologic inhibition of ASAH1 increases
oHSV-mediated cell death of BTICs derived from parental and temozolomide-resistant patient-derived
xenografts. We will also explore whether there are additional benefits for targeting ASAH1 in the tumor
microenvironment through effects on glioma associated macrophages/microglia. We anticipate that the studies
proposed here will provide key preliminary data to support a larger research program to determine whether
shifting the sphingolipid rheostat is an effective therapeutic strategy to improve immunovirotherapy in GBM.

Public health relevance
PROJECT NARRATIVE Herpes oncolytic virus shows great promise for the treatment of brain tumors, but the altered sphingolipid metabolism of cancer may limit efficacy. Shifting the balance of sphingolipids could impact the brain microenvironment to improve immunotherapy treatments for brain tumors.